Targets of Oxytocin Receptor Signaling

Oxytocin is an evolutionary conserved peptide hormone that is synthesized and released from
the hypothalamus for reproduction and maternal behavior. Recent studies have tagged oxytocin as a
“trust” hormone, that promises to improve social deficits in various mental disorders, such as autism.
Despite the enthusiasm for oxytocin, the efficacy of oxytocin in improving human social behaviors has
been contradictory. Such inconsistencies are likely due to our poor understanding of complexity of
oxytocin action and the behavioral measures that have been used in clinical trials. A better
understanding of the mechanisms of oxytocin is needed to apply the therapeutic potential of this
neuropeptide. Recently we showed that oxytocin enables mice to recognize infant distress calls through
the auditory system that enhanced maternal pup retrieval thru oxytocin receptors. The hypothesis of
this application is that the identification of downstream targets of oxytocin receptors will provide a
means of analyzing oxytocin signaling across molecular, physiological, systems and behavioral levels.
We have developed new assays and antibodies to follow the action of the oxytocin receptor, a G
protein-coupled receptor. The aim of this project is to understand how the many actions of oxytocin
are translated from its receptor signal transduction pathways. An initial goal will be to follow the
downstream proteins that mediate the functions of oxytocin. This includes G proteins, calcium-
dependent proteins, scaffold proteins like gephyrin and receptor tyrosine kinases, such as the BDNF
TrkB receptor.

Public health relevance
Oxytocin is an important neuropeptide that is responsible for many higher order activities, such as social recognition, plasticity and cognition. Because of its pro-social effects on maternal care, affiliation and social attachment, oxytocin has been proposed as a treatment for anxiety and autism spectrum disorder. However, its use has limited potential until the actions of its receptor is better defined. A mechanistic understanding of the role of oxytocin in signal transduction is relevant to neural mechanisms of social cognition and anxiety-related behaviors.